Engineering in vivo half-life extension of a novel mammalian asparaginase to increase feasibility of pan-cancer therapy

Project Summary:
The goal of this proposal is to extensively broaden the clinical applications of the unique anti-cancer biologic
drug L-asparaginase (ASNase) by developing a longer-acting next generation version of our novel variant, EBD-
300, currently in IND-enabling studies. ASNases are enzyme drugs that exploit a metabolic vulnerability of
specific tumor cells via systemic depletion of L-asparagine (Asn) from the blood, and they are critical in the
treatment of pediatric acute lymphoblastic leukemia (ALL). Cure rates greatly improved upon incorporation of
ASNase into pediatric treatment protocols, however, adult ALL patients are largely precluded from ASNase
treatment due to the toxicity from current FDA-approved versions. The result is significantly lower overall cure
rates for adults with ALL. The side effects of current ASNases stem from two causes – one is their
immunogenicity due to their bacterial origin and the second is their off-target L-glutaminase (GLNase) co-
activity. To expand the use of this drug to adult ALL patients and other indications, there is a need for a superior
ASNase with (1) reduced immunogenicity, (2) devoid of GLNase activity, and with (3) long in vivo
persistence. To begin addressing this need, EbD developed EBD-300, the 1st mammalian ASNase (derived
from guinea pig and further humanized to reduce immunological risk) and the 1st super specific ASNase (zero
GLNase). In vivo studies demonstrated high efficacy of EBD-300 in ALL, with vastly superior safety compared
to the current 1st-line (Oncaspar) and 2nd-line (Rylaze) FDA-approved ASNases. The in vivo persistence (t1/2) of
EBD-300 is much longer than Rylaze, making it a promising candidate to become the preferred 2nd-line ASNase.
However, EBD-300 is not competitive with 1st-line Oncaspar/Asparlas because of its need for a higher and more
frequent dosing schedule. Notably, over 130 customer discovery interviews with KOLs in ALL revealed the strong
need for a long-acting EBD-300 variant to be able to break into 1st line. The work proposed here will engineer
and test next generation EBD-300 variants with long in vivo persistence, and such a long-acting variant will both
impact ALL patients and provide the ultimate ASNase for additional indications (where, until now, current
ASNases are simply too toxic for these adult populations). This includes blood cancers such as acute myeloid
leukemia and solid tumors, like liver and colorectal cancers, all of which have been shown preclinically to be
sensitive to ASNase. To achieve this goal, we will engineer EBD-300 with a novel half-life extension (HLE)
technology in a 3-step process. Step 1 will generate HLE EBD-300 variants and confirm that the modifications
maintain the required enzymatic properties for clinical efficacy. In Step 2, the top 3 variants passing stringent QC
will have their in vivo persistence evaluated. The top candidate will proceed to Step 3 to confirm its anti-ALL
power in mouse models. The feasibility of our approach to generate a long-acting EBD-300 variant has been
proven in our preliminary work. Success here will provide a novel ASNase to dramatically impact the
treatment of ALL and expand to other cancers that rely on blood Asn for proliferation and survival.

Public health relevance
Project Narrative: L-asparaginases (ASNases), which are essential drugs for treating pediatric acute lymphoblastic leukemia (ALL), also have tremendous potential for use in adults with ALL – as well as other indications including both solid and blood tumors – were it not for the severe toxicity seen with today’s FDA-approved ASNases, especially when given to adults. In previous work, we developed a novel mammalian ASNase, EBD-300, that is significantly better tolerated than the currently approved bacterial versions, while still maintaining the same high efficacy. In this application, we will engineer a next generation version of EBD-300 to have a significantly longer in vivo persistence, which is an essential property for this drug to become the most impactful in 1st line ALL treatment and in the treatment of additional cancers comprising mainly adults where patients can be selected based on biomarkers for sensitivity to asparagine depletion.